Personalized Comorbidity-Integrated Gout Care

Candidate: Chio Yokose, MD, MSc is an Instructor in Medicine at Harvard Medical School (HMS) and an
Assistant in Medicine in the Division of Rheumatology, Allergy, and Immunology at Massachusetts General
Hospital (MGH). After graduating Brown University magna cum laude with her BA in Biology and East Asian
Studies, she received her MD from Northwestern University. She completed her internal medicine residency at
New York University and her rheumatology fellowship at MGH. She also received her MSc in Epidemiology from
the Harvard T.H. Chan School of Public Health. Dr. Yokose conducts patient-centered research focused on gout
and its cardiometabolic comorbidities under the mentorship of Hyon Choi, MD, DrPH. Her research has resulted
in 17 peer-reviewed original manuscripts (eight as first-author). Her goal is to become an independent
investigator and leader in personalized, patient-centered gout research.
Mentorship, Training Activities, and Environment: Dr. Yokose will conduct the proposed project at MGH
under the mentorship of Hyon Choi, MD, DrPH and co-mentorship of David W. Bates, MD, MSc and Maria Edelen,
PhD. Dr. Choi is a world-renowned, NIH-funded physician investigator with expertise in advanced epidemiologic
methodologies and risk factors for incident gout. Dr. Bates is a preeminent expert on leveraging medical
informatics to conduct patient safety, quality, and clinical effectiveness research. Dr. Edelen has extensive
expertise in the development, implementation, analysis, and interpretation of patient-reported outcomes
measures (PROMs). Drs. Choi, Bates, and Edelen all have extensive experience mentoring trainees and junior
faculty, including multiple prior K awardees. Dr. Yokose will also benefit from the specific expertise of her key
collaborators, including pharmacoepidemiology methods and latent class analysis. Under the guidance of her
mentorship team, she will acquire skills in new research areas including comparative effectiveness research,
research using real-world data, and patient-centered outcomes research using biomarkers and PROMs.
Research: The morbidity and mortality burden of gout and its cardiometabolic comorbidities continues to rise.
These trends highlight the limitations of our current gout care model in which gout and comorbidities are
managed independently. The central goal of this research is to examine the gout benefits of pleiotropic
cardiometabolic medications and identify a framework for the personalized integration of gout and comorbidity
care to synergistically address gout and comorbidities and ultimately improve outcomes for patients with gout.
To achieve this, Dr. Yokose will conduct rigorous comparative effectiveness research examining the serum urate-
lowering potential of common cardiometabolic medications (Aim 1) and determine comorbidity phenotypes of
incident gout and their relations with serum urate change (key causal precursor to gout) and PROMs related to
gout care barriers (Aim 2). By completing this proposal and training plan, Dr. Yokose will gain critical experience
to become an independent clinical researcher and leader in personalized, patient-oriented gout research.

Public health relevance
PROJECT NARRATIVE Gout is the most prevalent inflammatory arthritis with a worsening global disease burden and a substantial and rising prevalence of cardiometabolic comorbidities, which in turn contribute to premature mortality. These trends highlight the shortcomings of our current approach to gout care and call for personalized comorbidity- integrated models of gout care with the potential to synergistically address gout and its comorbidities. This Career Development Award proposes to leverage real-world and patient-derived data to conduct rigorous comparative effectiveness studies to examine the gout benefits of pleiotropic cardiometabolic medications and identify comorbidity phenotype clusters of incident gout and their associated outcomes to inform personalized comorbidity-integrated gout care and help improve both gout morbidities and comorbidities.